Eating and Feeding Behavior: Exploring Phenotypes and Influencing Outcomes

This year, this project focused on iteratively building and evaluating the use of virtual reality technology to teach individuals concepts related to the role of gene-environment interaction in eating behaviors. Data to evaluate the educational materials to be used in this project have been collected in internet-based surveys in several waves; manuscript preparation is underway. User testing of the virtual reality experience is also under way. Additional stages of this study are planned but data collection has not yet started.

In a Twitter-based project we are evaluating the information environment that community members and members of the public encounter when considering nutrigenetics/nugrigenomics using quantitative content analysis.